ALTERNATIVE MOLECULAR VISUALIZATION TECHNOLOGIES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Interactive molecular visualization and analysis is typically done using desktop computers, standard 3-dimensional video game graphics, and mouse and keyboard input devices. This standard platform is well-suited for 2-dimensional visualization but is not ideal for viewing and manipulating 3-dimensional models. A wide variety of alternative technologies can complement this traditional computer graphics environment and enable more productive methods of 3-dimensional data analysis. All of these methods are currently rather exotic being use by at most a few percent of molecular structure researchers. This project explores and promotes technologies that may become next-generation analysis methods. Specific technologies we are exploring include printing 3-dimensional plastic models using rapid-prototyping machines from mechanical engineering, making lenticular images which are printed scenes that provide depth perception without special glasses, new stereo displays using flat panel displays and polarized or shutter glasses, using the Nintendo Wii game controller or web cameras to track user head-motion to control view angle in a scene, using 6 degree-of-freedom input devices for rotation and moving objects in a scene. We present the results of many of these technology studies in a "Technology Notes" section of our Resource center web site. http://www.cgl.ucsf.edu/Outreach/technotes/index.html